Augmented Reality System for the Education of Clinical Caregivers of Older Adults

Project Summary/Abstract The value of mannequin-based simulation is well recognized and is incorporated extensively into medical education. In general, their primary purpose is to simulate a physical patient on which to learn, demonstrate, and test skill without fear of harming patients prior to entering clinical environments. Despite their substantial benefits, they have several fundamental limitations. Proposed is a system to combine and leverage the advantages of both existing physical mannequin-based training and virtual media to support clinical learning using Augmented Reality (AR). This Phase I project will focus on creating and evaluating a proof of concept system. An engaging, interactive training course using the prototype system will be developed as a case study for clinical nursing training on pressure injuries ? an oftentimes preventable injury that is attributed to tremendous human suffering and represents a significant cost burden on our health care system. The course will leverage existing mannequin-based training used at the UMN and be evaluated by both instructors and students at the School of Nursing.

Public health relevance
Project Narrative Over the past decade, medical simulation has been experiencing explosive growth and widespread adoption. There are now over 800 medical simulation centers in the US alone, located in medical schools, nursing schools, hospitals, military simulation centers, and schools of allied health professions. The global market for Mannequin-Based Simulation is projected to reach $1 Billion by 2020. It is hypothesized that the combination of existing physical mannequin-based training with virtual media will opens new possibilities for exploration and enhanced learning interactions for medical education.